STUDIES OF NEW VACCINES

We are using the CLINFO system to manage the large amount of data obtained in our outpatient studies of new vaccines, including acellular pertussis, cytomegalovirus, varicella, rotavirus, hepatitis B and H. influenza type B. CLINFO enables us to do statistical analysis of the data.